Interaction of Yersinia with dendritic cells

DESCRIPTION (provided by applicant): Yersinia pseudotuberculosis is a close relative of Yersinia pestis, the etiologic agent of plague, and has been studied as a model for understanding mechanisms of Yersinia pathogenesis. All members of the genus Yersinia are highly lymphotropic and possess common virulence factors that interfere with cellular signaling and activation pathways. The YopJ protein causes cell death in macrophages as well as blocking cellular activation pathways. A second virulence factor, YopH, interferes with T and B lymphocyte functions. Although numerous studies have highlighted the key role played by dendritic cells (DCs) in stimulating and directing immune responses, little is currently known about the interactions between Yersinia and DCs and the ability of Yersinia to interfere with DC functions. This proposal outlines a plan to examine the impact of Yersinia infection on the ability of DCs to orchestrate adaptive immune responses. This work should lead to new understanding of the nature and mechanisms by which pathogens manipulate host immune responses, and potentially to new knowledge of host resistance mechanisms. This knowledge will be important in the development of future strategies against human pathogens.